GLYCOSPHINGOLIPIDS AND GM1-CHOLERA TOXIN INTERACTIONS

DESCRIPTION: Dr. Shipley's overall objectives have been: (1) to define the structure, properties and intermolecular interactions of the complex polar lipids which constitute important structural and functional components of both the bilayer matrix of cell membranes and the monolayer surface of plasma lipoproteins; and (2) to study membrane receptor-ligand interactions as individual macromolecules, as two-dimensional arrays on lipid surfaces, as three dimensional crystals, and in detergent-solubilized or vesicle-reconstituted systems. The rationale was that the structural definition of lipids is a prerequisite for successful experiments with reconstituted membrane receptor-ligand systems. In this proposal, Dr. Shipley focuses on: (1) the structure and properties of glycosphingolipids (GSL), (2) the interactions of GSL with other membrane lipids, and (3) the role of GSL as receptors for bacterial toxins, with emphasis on the ganglioside GM1-cholera toxin system. Aim 1: Glycosphingolipid Structure and Interactions: to define the role of increasing oligosaccharide complexity on the structure, properties and interactions of GSL. The Shipley group's successful de novo synthesis of ceramides and cerebrosides will be extended to globosides and gangliosides. Dr. Shipley will define the structure and properties of these GSL and their interactions with phosphatidylcholine and cholesterol using x-ray diffraction, differential scanning calorimetry, and electron microscopy techniques. The hypothesis being tested is that increasing GSL oligosaccharide complexity will progressively alter their phase behavior and that this in turn will produce defects in host bilayer structure. Aim 2: Cholera Toxin/Ganglioside GM1 Interaction: to complete the structural studies of CTX, its B5-pentamer CTB, and their interaction with their receptor GM1. Dr. Shipley will focus on CTX and CTB bound to GM1-containing vesicles and will test the hypothesis that the membrane translocation step for the catalytic A1 domain is triggered by changes in pH. In parallel, crystallographic studies of CTX and CTB grown at low pH will be developed.